UTMB Claude D. Pepper Older Americans Independence Center

PROJECT SUMMARY/ABSTRACT (OVERALL)
The University of Texas Medical Branch (UTMB) Claude D. Pepper Older Americans Independence Center
(OAIC) has been funded since 2000. It is the home of a diverse multidisciplinary team of investigators with
complementary research interests in aging. We have discovered mechanisms of sarcopenia in cells, animal
models and humans; identified trajectories of functional loss and disability in diverse populations; developed
and tested interventions to improve functional recovery and independence. We have trained 31 Scholars (45%
women, 26% minority), and published more than 640 papers.
In the next cycle, we will build on our established infrastructure and accomplishments to support innovative
multidisciplinary research and train the next generation of leaders in gerontology and geriatrics. The UTMB
OAIC’s guiding theme is “Translate Pathways of Function Loss and Gain into Interventions to Optimize
Functional Recovery in Diverse Geriatric Populations”.
Our program’s aims are:
1. Discover mechanisms and define trajectories of age-related functional loss and gain.
2. Develop and test innovative interventions to optimize functional recovery.
3. Translate interventions to the clinical setting in diverse populations.
4. Train the future leaders in gerontology and geriatric research.
We will use an integrative approach to translate basic discoveries into interventions for functional recovery and
improve the trajectories of functional loss and disability in older adults. By leveraging partnerships with other
institutional programs, we will expand our research in the select areas of novel therapeutics, Hispanic aging,
and recovery from neurologic diseases. We will pursue our aims by integrating the activities of our highly
productive Resource Cores: Metabolism and Biology, Clinical Research, and Biostatistics and Data
Management. The Leadership and Administrative Core will provide the scientific leadership and coordinate the
resource cores’ activities with those of the Pilot/Exploratory Core and the Research Education Core to spark
research innovation and develop the leaders of the future.

Public health relevance
UTMB OAIC PROJECT NARRATIVE (OVERALL) The University of Texas Medical Branch Claude D. Pepper Older Americans Independence Center (UTMB OAIC) will identify the pathways that lead to functional loss with aging and translate these discoveries into interventions for the promotion of functional recovery and independence in the growing diverse population of older Americans. The UTMB OAIC will use its highly productive and integrated research and training infrastructure to ignite new research, develop novel methodologies, support externally funded research, develop and support new collaborations with other programs and train the future leaders in aging research and geriatrics.